An immunomodulatory and vascularized cell delivery device for type 1 diabetes cell therapy

PROJECT SUMMARY
An immunomodulatory and vascularized cell delivery device for type 1 diabetes cell therapy
The overall goal of this proposal is to develop a cell-retaining, subcutaneous device that allows blood
vessel penetration and establishment of an immunotolerant environment for islet delivery for type 1
diabetes cell replacement therapy. Transplantation of human cadaveric islets and more recently human
stem cell-derived insulin-producing cells has shown great promise as a curative therapy for T1D patients.
However, delivering the cells safely and maintaining their long-term function without immunosuppression
remains a daunting challenge. In principle, encapsulating the cells in a semi-permeable biomaterial or
device can protect the cells from the immune system but the approach introduces a physical barrier and
prevents direct vascularization, diminishing the mass transfer and cellular function over time. On the other
hand, the “open” approach aims to support cell engraftment by establishing an immunotolerant local
environment and allowing host integration and vascularization. We recently developed a cell-mediated
“open” approach where we co-transplanted genetically engineered “nurse” cells (engineered mesenchymal
stromal cells over-expressing PD-L1/CTLA-4Ig, or eMSCs) together with islets to induce local
immunotolerance for immunosuppression-free allogeneic islet engraftment in mouse kidney capsules.
However, a caveat in our approach that limits its long-term efficacy is that the eMSCs, similar to numerous
MSC products that are currently evaluated in clinical trials, are migratory and they do not stay co-localized
with islets. To overcome this cell retention problem, we engineered an electrospun nonwoven cell delivery
device that retained the MSC cells while allowing capillary penetration in subcutaneous space of mice. The
objective of this project is to test the hypothesis that improving the retention of eMSCs and their co-
localization with islets in this cell-retaining, vascularized “open” device will enhance the immunomodulatory
effects and prolong the therapeutic efficacy of allogeneic islet transplantation in a clinically attractive
subcutaneous site. Successful completion of this project will result in the development of an
immunomodulatory device that can be subcutaneously implanted, enabling both capillary penetration and
establishment of an immunotolerant environment for islet engraftment without requiring chronic systemic
immunosuppression.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) affects over 1 million people in US and current therapies based on insulin injections or infusions are tedious, painful and imperfect. The goal of this project is to develop a translatable immunosuppression-free cell replacement therapy for T1D by engineering a subcutaneously-implanted, vascularized, immunomodulatory, scalable and long-term functional islet delivery device.